Immune repertoire remodeling following B cell-targeted CAR T cells for induction of renal allograft tolerance in non-human primates

Abstract:
Kidney transplantation is the treatment of choice for patients with end-stage kidney disease.
Potent T cell directed immunosuppression has led to excellent short-term allograft survival.
However, chronic immune rejection remains a significant challenge as rejection constitutes the
most common reason for kidney failure and return to dialysis. Induction of immune tolerance
serves the dual benefits of preventing rejection of the kidney and salvage of recipients from
toxicities associated with chronic immunosuppression. Our preliminary studies in a murine model
indicated a requisite role of B cell antigen presentation in activation of alloreactive CD4 T
lymphocytes. Therefore, our contention is that the induction of robust transplantation tolerance
will require unresponsiveness at the level of both the B- and T-cell compartments. As such, we
performed preclinical trials of kidney transplantation in Cynomolgus macaques utilizing a
combined induction immunotherapy regimen, which included a CD20-specific B cell depleting
monoclonal antibody (Rituximab) and T cell depletion with Thymoglobulin. This regimen led to
marked prolongation of allograft survival in some recipients. However, a majority of allografts
succumb to immune rejection with development of donor specific antibodies. Importantly, we
demonstrated that prolonged survival was correlated with the re-emergence of the B cells with an
immature/naive phenotype. In animals with early allograft loss, the re-emerging B cell
compartment was predominantly composed of activate/mature B cells, suggestive of residual
Rituximab-resistant tissue-resident B cell clones. Therefore, we contend that stringent B cell
depletion is a prerequisite for robust B and T cell repertoire modification toward a tolerant state.
The present application utilizes a CD20-targeted CART cell therapy to achieve stringent B cell
depletion permitting regeneration of the B cell compartment in the presence of the kidney allograft
to recapitulate the ontogeny of B cell tolerance. Importantly, since B cells are potent APCs for T
cell priming, the impact of B cell repertoire modification has the potential to provide tolerogenic
signals to a responding allo-reactive T cell pool. We test this concept in the setting of kidney
allo-transplantation in Cynomolgus monkeys. Mechanistic studies will interrogate both B and T
cell alloimmunity at the cellular and molecular levels. Finally, we will develop an mRNA-LNP
based method of in vivo CAR T cell generation to facilitate clinical translation. Overall, this
proposal develops new therapeutics and introduces novel technologies to the NHP model with
the ultimate goal of clinical translation.

Public health relevance
Narrative: The rejection of transplanted organs places a major burden on public health resources in the United States. Furthermore, the requirement for life long immunosuppression to maintain transplant function not only poses a major cost burden on the health care system, but also imposes a dramatic degree of morbidity on the recipient. In this application, we leverage breakthrough technologies in the field of gene engineered T cell immunotherapy to target recipient B lymphocytes in order to induce donor specific immunological tolerance to transplanted kidneys as a cure for end stage kidney diseases.